MONKEY RHADINOVIRUS, A MONKEY MODEL FOR HUMAN HERPESVIRUS 8

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Rhesus monkey rhadinovirus and the rhesus lymphocryptovirus are being developed as monkey models for human herpesvirus 8 and human Epstein Barr virus infection. We are interested in tropism, the glycoproteins used for entry, persistence and the contributions of individual viral genes. AIDS related.